Molecular mechanisms of gap junction promotion of lesion formation in Endometriosis

ABSTRACT
This request for a Supplement to RO1HD109027 is in response to RFA NOT-OD-22-208 that addresses several
of the priority ORWH Strategic Plan Objectives related to disparities in Women’s Health, specifically:
1.5 (Research on gynecological health, including infertility): Endometriosis is a major issue in gynecological
health affecting 10% of women worldwide, of whom as many as 50% suffer problems of infertility
2.2 (Development of biomarkers for women’s health): The current work arises from our development of a much-
needed non-surgical diagnostic that is being developed by Hera Biotech (co-founded by the PI and Co-I), who
are sponsoring the clinical trial which will provide material for study here to assess if the diagnostic is equally
effective across different ethnic groups, and if it reveals different severity of disease.
2.4 (Examination of health disparities stemming from factors such as race and ethnicity). We will expand
functional tests on patient endometrial cells proposed in the parent RO1 to definitively test if there are Biological
or epigenetic differences that could explain the 3-fold lower rate of diagnosis and 2 fold lower hospitalizations for
endometriosis in the Hispanic (and Black) populations compared to non-Hispanic Whites. Absence of such
evidence will provide the first hard data to support efforts to address the socioeconomic inequities responsible.
The work proposed will utilize our expertise in single cell analysis (Co-I is Director of the Bioanalytics &
Single Cell Facility) and ex-vivo functional analyses of cell interactions and invasiveness developed in the
Nicholson lab under the parent RO1. We will also utilize our unique S. Texas Ob/Gyn repository of separated
endometrial stromal and epithelial cells, which will be trebled in size through the on-going Hera Proof-of-Concept
trial. With ~30% of samples being of Hispanic origin, this allows us to conduct the first ever in-depth comparison
of gene expression patterns (Aim 1) and cellular phenotypes (Aim 2) between Hispanic and non-Hispanic white
control and endometriosis patients. The scope of this short-term study will be kept manageable by focusing in
Aim 1 on proteins in the “cell-interactome” – cell components involved in intercellular communication (gap
junctions), contact (tight and adhesion junctions), accessory components and regulatory factors (including
mediators of epithelial to mesenchymal transition). The Aim 2 functional studies will have a similar focus,
concentrating on peritoneal invasiveness in a 3-D ex-vivo model using established and primary mesothelial cells,
and measurements of intercellular coupling via gap junctions, as we have demonstrated this to be required for
invasion. Should differences be detected, they will provide important guidelines for future personalized
therapeutics. Should no differences be observed, it will provide a compelling, data-driven mandate to address
the socio-economic or unconscious bias issues that contribute to ethnic disparities in endometriosis treatment.

Public health relevance
Narrative Endometriosis is a pervasive and debilitating disease that affects 10% of women, yet diagnosis remains a major problem, as it is chronically delayed by an average of 7 years, and has one of the greatest ethnic/racial disparities of any disease (diagnostic frequency among Asian, non- Hispanic White, Hispanic and Black patient are 2 - 1 - 0.3 - 0.3 – a differential of 6 fold!!). We propose here to extend our mechanistic studies into the molecular and cellular bases of endometriosis to conduct the first in depth analysis of ethnicity differences in endometriosis pathophysiology by leveraging our unique biorepository from S. Texas (~1/3rd Hispanic) and our array of functional tests. The studies should provide the first concrete evidence as to whether there are genuine underlying ethnic differences in endometrial biology that contribute to disease frequency, or if we need to focus all efforts on socioeconomic inequities that hinder diagnosis.